New Generation of General AMBER Force Field for Biomedical Research

Project Summary
Molecular simulation plays an essential role in biochemical and biophysical research. Its major
application is to decipher molecular interactions between small molecule ligands and
biomolecules, especially protein receptors, so that highly potent agonists or antagonists can be
discovered to enhance or eradicate target functions. Despite tremendous efforts spent on
development, it is still very challenging to accurately predict protein-ligand binding. To overcome
the challenge, we need (1) to develop a high-quality molecular mechanics force field (MMFF) to
accurately describe the energetics of the simulation systems, and (2) to apply a sampling strategy
which can effectively sample “hidden” events that are coupled with state transitions. The major
goal of this project is to develop and test the 3rd generation of the general-purpose AMBER force
field of GAFF (GAFF3) to significantly improve the quality of the AMBER small molecule force
field. GAFF3 will be critically evaluated in studying biomolecule-ligand interactions using a novel
GPU-accelerated 𝜆-dynamics based orthogonal space tempering (OST) algorithm. The advanced
sampling technique will guarantee that our macromolecule-ligand binding free energy calculations
are not complicated by existing sampling issues so that GAFF3 can be objectively evaluated. The
study includes three specific goals: (1) to develop GAFF3 utilizing ABCG2, a new physical charge
model which has demonstrated its superior performance in large scale solvation free energy
calculations. Large-scale ab initio calculations will be performed for drugs and druglike screening
compounds to derive force field parameters; (2) to critically evaluate the GAFF3 performance in
studying biomolecule-ligand interactions using both pathway-based and endpoint free energy
methods using GPU computing. The OST sampling method will be continuously developed and
implemented for this evaluation effort; and (3) to apply a variety of strategies to handle “difficult”
molecules identified by us or our users. The strategies will include fine atom typing and
introduction of new functional forms. We believe that these efforts will allow GAFF3 to approach
the performance limit an additive model could have. The successful pursuit of these research
aims will facilitate us to surmount the challenges in accurately modeling protein-ligand and nucleic
acid-ligand binding.

Public health relevance
Project Narrative Molecular mechanical force field is the foundation for accurate prediction of the structures, energetics and dynamics of biomolecular systems. We plan to develop a new generation of general AMBER force field (GAFF3) for studying biomolecule- ligand interactions. GAFF3 will be critically evaluated in protein-ligand and nucleic acid-ligand binding free energy predictions using a novel GPU-accelerated λ- dynamics based orthogonal space tempering (OST) algorithm. We will apply a variety of strategies to further improve the performance of GAFF3 until it approaches the best performance an additive force field model can achieve.